Whole-Body PET/MR scanner

Project Summary
This proposal seeks support for a dedicated research PET/MR system for the Yale School of Medicine, featuring
a TOF PET instrument integrated with a high-resolution MR system. This system is the first of its kind in the
State of Connecticut and will enhance multiple research projects and training grants. Benefits include improved
protocol workflow, multinuclear spectroscopic imaging, MRI-enhanced PET images (motion and partial volume
correction), increased lesion detection sensitivity, and radiation dose reduction. Advances in MR and PET
imaging have spurred significant research in modeling, image reconstruction, and clinical applications, enabling
extraction of crucial physiological information. Together the two modalities are even more powerful. MRI can
offer additional functional and anatomical information beyond PET, such as diffusion-weighted imaging (DWI),
perfusion-weighted imaging (PWI), functional MRI (fMRI), and magnetic resonance spectroscopy imaging
(MRSI). Integrating these modalities with PET can provide a more comprehensive understanding of biological
processes under investigation. The simultaneous acquisition enables better spatial and temporal alignment
between the modalities and improves image fusion accuracy and reduces motion artifacts, which is particularly
useful in dynamic imaging studies or applications requiring precise localization, as is true of many of the projects
at Yale. Combining the two modalities also reduces the number of scans needed for a subject, increasing their
comfort and decreasing overall costs and scheduling complications. The essential administrative and technical
leadership is already in place at Yale to ensure efficient utilization of this instrumentation. The Yale School of
Medicine has agreed to provide funding to cover the balance of the cost of the scanner along with renovation
costs and seed funding for pilot studies. The proposed PET/MR system with its unique capabilities will be a major
asset to a community of NIH-funded investigators and likely lead to major innovations in PET/MR imaging
research.

Public health relevance
Narrative This project proposes to install the first PET/MR research scanner in the State of Connecticut at Yale University. This combined modality scanner is crucial given the acute need for additional imaging capacity at Yale. It will enable the expansion of existing preclinical and clinical research projects and catalyze new applications led by NIH investigators currently using PET and MR separately.